The role of valence encoding amygdala ensembles in avoidance behavior

PROJECT SUMMARY
The ability of an organism to rapidly and accurately assess whether an environmental stimulus is worth
approaching or avoiding, also known as valence, is critical to survival. One brain region necessary for this
computation is the basolateral amygdala (BLA), which contains discrete ensembles of anatomically intermixed
excitatory principal neurons that respond selectively to either positive- and negative-valence stimuli. Recently, I
demonstrated that multiphoton activation of these activity defined valence ensembles was sufficient to bias
valence-specific behavioral output via mutual ensemble inhibition. However, how this inhibition is generated and
its relevance to avoidance behavior is not known. In this proposal, I first aim to determine how functional
antagonism of valence-selective ensembles is generated (Aim 1: K99) using chronically implanted
microprisms to record the simultaneous activity of both GABAergic and glutamatergic principal neurons during
valence stimulus testing. After mapping activity, I will perform microcircuit mapping using multiphoton activation
of individual parvalbumin-expressing (PV) interneurons to establish the rules that govern their valence ensemble
connectivity and relevance to valence-specific behavioral output. Next, I will identify how antagonistic valence
ensemble activity is modulated during avoidance (Aim 2: K99). Using two-photon GRIN lens imaging and a
novel specialized conversion adapter allowing for image registration between both freely moving 1-photon
calcium and 2-photon imaging, I will determine how valence ensembles in the BLA are modulated avoidance. I
will then generate computational models to identify specific ensembles responsible for encoding avoidance
behavior. I will then target these ensembles for multiphoton inhibition to assess their role in producing avoidance
behavior. Finally, I will isolate how norepinephrine (NE) release from the locus coeruleus (LC) alters BLA
ensemble activity through gain control to promote avoidance behavior (Aim 3: R00) to identify the
endogenous signal that is governing BLA ensemble recruitment to promote avoidance behavior. Using combined
optogenetics and fiber photometry I will first measure NE release in the BLA following an acute stressor, and
compare this to release evoked by optogenetic activation of LC terminals in BLA. I will then conduct 1-photon
calcium imaging, avoidance behavioral assays, pharmacology, and graph theory analyses, I will evaluate
whether activation of LC terminals in BLA alters ensemble activity via β2-adrenergic receptors (ARs). The training
received following the completion of this proposal will facilitate my transition to running an independent laboratory
focused on neuromodulation of avoidance circuits.

Public health relevance
PROJECT NARRATIVE The basolateral amygdala (BLA) contains discrete ensembles of anatomically intermixed neurons that respond to positive and negative valence stimuli, though how these ensembles interact and coordinate to facilitate approach and avoidance is not known. Here I propose to use two-photon imaging and multiphoton activation and suppression to elucidate the microcircuit governing valence encoding amygdalar ensemble formation, establish the necessity of negative valence ensemble activity for avoidance behavior, and identify the neuromodulatory input that regulates ensemble formation endogenously.